Molecular Mechanisms of Emmetropization and Experimental Myopia at Single Cell Resolution

PROJECT SUMMARY
More than half of the world’s population is projected to be myopic (nearsighted) by 2050, significantly raising the
risk of associated vision-threatening conditions including retinal detachment, maculopathy, and glaucoma.
Despite the development of several evidence-based treatments to manage myopia progression, the prevalence
and complication rates continue to rise, and treatment efficacy is only partial. Experimental and clinical research
shows that complex gene-environment interactions are involved in the control of the post-natal growth of the eye
and its optical development, including myopia onset and progression. Research using animal models has
confirmed that visual experience and retinal defocus control eye growth and the development of refractive state
through the process of emmetropization. While progress has been made uncovering some of the biochemical
factors associated with experimental myopia, very little is known about the underlying cellular and molecular
mechanisms controlling emmetropization and myopia development.
This multi-PI consortium grant brings together experienced researchers and their established experimental non-
human primate model of emmetropization and myopia with an internationally recognized ocular genomics
research center to perform a major investigation of the retinal, RPE, choroidal, and scleral biology of post-natal
eye growth and myopia development. This project examines the functional genomics and gene-environment
interactions in the refractive development of the primate eye and will identify molecular mechanisms involved in
the development of myopia using single cell and bulk transcriptomics, epigenomics, and proteomics. The
investigators will identify and confirm, using established bioinformatic approaches, the main components of key
regulatory pathways underlying emmetropization and myopia development. These studies will provide direct
evidence and a more complete understanding of the mechanisms of visually regulated eye growth and myopia
and will provide the largest and most comprehensive shared resource of cellular and molecular targets to date
helping develop new therapies to control eye growth and manage refractive errors.
This investigation meets three of the four NEI objectives for myopia research: to investigate the biochemical
pathways that regulate eye growth; to identify genes that contribute to the development of refractive errors; and
will help develop new technologies for assessing or treating refractive errors.

Public health relevance
PROJECT NARRATIVE Myopia (nearsightedness) is a leading cause of vision impairment. It is a growing public health concern because its prevalence is increasing significantly, which increases the prevalence of several vision-threatening conditions associated with myopia and more vision loss. This project examines gene expression in the eye to identify the cellular and molecular mechanisms controlling eye growth and the development of myopia. The results will provide important insights about the causes and control of myopia in children and form the basis for new and effective treatments to reduce myopia and vision loss.